Delineation of unique flagellar proteins in spirochetes

Pathogenic spirochetal bacteria cause serious illnesses—Syphilis, Leptospirosis, Periodontal disease, and
Lyme disease—throughout the world. Despite these debilitating diseases, spirochetes remain poorly studied.
Spirochete-specific research is crucial and urgently needed for the development of new treatment modalities.
Spirochetes are well recognizable due to their distinctive spiral or wave-like morphology and cork-screw type
motility. The organelles essential for the unique morphology and motility of the Lyme disease spirochete
Borrelia burgdorferi are the periplasmic flagella, which are enclosed in the periplasmic space and are distinct in
assembly, structure, and function from external flagella in the model organisms Escherichia coli and
Salmonella enterica. Our goal is to understand the molecular mechanisms underlying the assembly and
function of the unique periplasmic flagellar proteins and their specific roles in spirochetal motility. Since motility
is crucial for pathogenic spirochetes to cause diseases in hosts, the objectives of the proposal are to,
demonstrate novel mechanistic insights into how spirochete-specific collar proteins help recruit and stabilize
sixteen stator complexes to generate high torque; discover and characterize novel flagellar proteins to gain a
mechanistic understanding of the unique collar architecture and its impacts on the assembly of periplasmic
flagella and motility of spirochetes; and to elucidate molecular mechanisms of how the collar proteins provide
solid bearing support to the rotary periplasmic flagella, and how they impact the assembly and orientation of
the flagella. These unique aspects of the periplasmic flagella are poorly studied. Three Aims are proposed to
better understand those objectives in Lyme disease spirochete B. burgdorferi. Aim 1 is to elucidate how the
flagellar collar proteins help recruit and stabilize the stator required for spirochetal motility. Aim 2 is to discover
and characterize novel flagellar proteins in spirochetes and their impacts on the motility of spirochetes and Aim
3 is to elucidate molecular mechanisms of periplasmic flagellar orientation in Borrelia burgdorferi. State-of-the-
art technologies including bioinformatics, genetic manipulations, microbiological, biochemical, and high
resolution cryo-electron tomography will be utilized to accomplish the proposed aims. The project is expected
to better understand the mechanisms of flagellar assembly and how they impact the very critical motility
function of the spirochetes. Knowledge obtained from this project can directly be applied to other pathogenic
spirochetes and diverse flagellated bacteria. Structure-based drug design targeting flagellar subunits present
an effective prevention strategy because motility is critical for pathogenic spirochetes to produce disease.

Public health relevance
Project Narrative: Spirochetes cause several serious diseases in humans and periplasmic flagellar motility is crucial for virulence by all pathogenic spirochetes. The novel studies outlined in this proposal are to delineate periplasmic flagellar assembly, orientation, bacterial morphology, and motility that are distinctive in the spirochetes. The virulence-associated flagellar structural proteins can lead to the development of a structure-based pharmacological agent to treat or prevent diseases caused by the spirochetes.